Single Cell Spatial Analysis

PROJECT SUMMARY/ABSTRACT (SINGLE CELL SPATIAL ANALYSIS SHARED RESOURCE)
The Single Cell Spatial Analysis Shared Resource (SCSA-SR) was a developing SR in the previous Cancer
Center Support Grant (CCSG) cycle. Due to high demand for its services and success in supporting Rogel
Cancer Center (Rogel) members, it is being transitioned to a full SR. The overarching goal of the SCSA-SR is to
provide the tools, expertise, and support needed to allow analysis of tumors at high depth of biomolecules with
high resolution, in both the context of individual cells and within the spatial context of tissue architecture. SCSA-
SR offers a variety of cost-effective services including single cell DNAseq, single cell RNAseq, CITE-seq and
spatial transcriptomics (both Visium and GeoMX) with associated bioinformatic support to provide an entry level
of analysis for Rogel members.